The University of Texas - Houston Stroke Training Program

This competitive renewal application requests 5 additional years of support for 4 post-doctoral trainees in
stroke and cerebrovascular disease to complete a 2 year fellowship. The program’s mission is to develop
neurologists to become clinician-scientists in stroke and cerebrovascular disease. Stroke remains the number
one cause of serious long-term adult disability; effective treatments are urgently needed. The specific aims of
the training program are to: (1) provide formal training in clinical and laboratory investigation of cerebrovascular
disease. The last 5 years of funding under the T32 Training Grant has resulted in significant expansion of our
stroke program into a university-wide Stroke Institute. Continued funding for another 5 years would therefore
allow us to: 1) provide uninterrupted growth of our research-mentoring program for stroke fellows; 2) train
ethnically diverse researchers and physician-scientists who will make an impact on treating cerebrovascular
disease. Our overall goal is to improve the care of stroke patients by mentoring clinician-scientists who will
dedicate their careers to investigating the pathophysiology and epidemiology of cerebrovascular disease and
applying this knowledge to new therapeutic advances and better stroke care delivery models. Faculty mentors
have been carefully selected to provide a multidisciplinary training experience in cerebrovascular disease.
Potential trainees must have completed a neurology residency and demonstrate a commitment to a career
carrying out research in cerebrovascular disease.

Public health relevance
The goal of our training program is to improve the care of stroke patients by mentoring and developing clinician scientists in the field of cerebrovascular disease. We seek continued funding for our training program which enables our fellows to conduct high-quality research in stroke and provides them critical support to launch their research based careers.